Dyadic Analysis of Unmet Social Needs Among Breast and Gynecologic Patients and Their Informal Caregivers

PROJECT SUMMARY/ABSTRACT
Psychological distress is prevalent in cancer patients and their informal caregivers (the intimate partners, other
family members, and friends who provide patients with crucial unpaid care and support). Distress has been
linked to poorer adherence to treatment and elevated mortality in patients, as well as negative outcomes for
caregivers. Whether patients or caregivers, women tend to report greater distress than men. Research on
patient-caregiver dyads has shown patients' and caregivers' physical and mental health is often intertwined,
but most prior dyadic work has analyzed predominantly middle-class spousal pairs. Given the persistent effects
of poverty and the longstanding health disparities by socioeconomic status in the United States, it is crucial to
understand the social context of financially vulnerable cancer patients and caregivers. Individual social
needs—including food, housing, or transportation—are associated with distress as well as physical health
outcomes in a range of contexts and populations. A growing body of research has analyzed single social
needs—most commonly food insecurity—among cancer patients in particular, but little is known about multiple
social needs in patients, how needs change over time, and whether the social needs of informal caregivers
affect patient outcomes. This study focuses on female patients with breast and gynecologic cancer—which
together account for over 400,000 newly diagnosed cancers among women annually—and their informal
caregivers. Our aims are: Aim 1. Document unmet social needs in patient-caregiver dyads (N = 300 dyads).
Analyze how needs affect patient and caregiver biopsychosocial outcomes including depressive symptoms
(primary outcome), physical and mental health quality of life, emergency department (E.D.) visits, and
treatment adherence (secondary outcomes). Aim 2. Analyze the experiences of patients and caregivers with
unmet social needs and explore their interest in and preferences for mental health and social needs
intervention. Use semi-structured dyadic interviews with 30 patient-caregiver pairs (N = 60 total participants) in
which one member reports at least one unmet need at baseline to explore participants' use of community
resources, whether they coordinate with the other member of the dyad to resolve unmet social needs, and their
preferences for screening and intervention. Aim 3. Explore the relationship between neighborhood-level
factors (census tract Area Deprivation Index and 2-1-1 helpline requests by ZIP code), social needs, and
depressive symptoms within dyads. This study will provide first-of-its-kind information about the
biopsychosocial effects of unmet social needs among female patients with cancer and their caregivers. A
central question is whether and how caregivers' social needs affect the patient. The answer will help us create
a targeted screening and intervention system to address the mental health and social needs of patients, and, if
warranted, caregivers. Our ultimate goal is to improve outcomes for women with cancer and their caregivers.

Public health relevance
PROJECT NARRATIVE Individual social needs—including food, housing, and transportation—are associated with biopsychosocial outcomes in a range of contexts and populations, but clinicians need to know more about how social needs affect cancer patients and their informal caregivers. This study will examine how the social needs of breast and gynecologic cancer patients and their caregivers affect both patient and caregiver outcomes in the year after diagnosis. Findings will inform targeted screening and intervention efforts to addresses the mental health and social needs of patients and caregivers.